Effect of Validated Skills Simulation with the Miya Model on Operating Room Performance of Vaginal Hysterectomy

Miya Model™ Simulator: Phase II B Abstract
OB/GYN Residents must develop numerous skills including pelvic exams, childbirth, open surgery,
laparoscopic surgery, and vaginal surgery. Studies demonstrate that OB/GYN Residents lack training in
vaginal surgical techniques, including Vaginal Hysterectomy (VH), the desired hysterectomy technique
recommended by The American College of Obstetricians and Gynecologists (ACOG) because it is associated
with less morbidity, quicker recovery and lower costs than abdominal hysterectomy. Furthermore, Residents
do not receive adequate training in vaginal surgery techniques used to treat urinary incontinence, fecal
incontinence or pelvic organ prolapse. The Miya Model™ is a complete female pelvic anatomy model
designed to simulate real surgical experiences including lifelike skin and life-sized organs, realistic cutting and
puncturing tensions, palpable surgical landmarks, a pressurized vascular system that bleeds when inadequate
technique is used, and an inflatable bladder that can leak water if damaged. The model is modular in that all of
the parts are designed as cartridges that are easily replaceable when damaged in a simulated surgery. The
anatomic correctness of the model can be used to train a broad range of health professionals on general
procedures like bimanual exam, speculum exam and pap smear, as well as advanced gynecologic vaginal
surgeries. There is no commercially available simulator that can train vaginal surgery skills and basic
gynecological procedures to a breadth of health professionals other than the Miya Model™. Phase I and II
SBIR programs developed curriculua for performing VH, sling techniques for incontinence, and completed a
Construct Validity study demonstrating that performance differences of novices and experts performing a VH
on the Miya ModelTM were measurable. Construct Validity is a crucial step in a simulator being accepted as an
assessment tool. Modifications suggested by surgeon feedback during the validation study were incorporated
into a production design making the Miya Model™ and replacement cartridges more affordable while
modifying the design based on surgeon feedback. Phase IIB will encompass four Specific Aims with the goal of
determining if training on the Miya Model™ and its associated curricula will improve VH performance in the
Operating Room (OR). This study will require assessing the baseline VH skills of Residents at six institutions,
dividing the Residents into two groups for either standard or simulation training, and subsequently comparing
the OR performance of both groups. When complete, the Miya Model™, curriculum, and assessment tools will
be a complete training system used in OB/GYN residency programs to train vaginal surgery techniques and
objectively assess surgical competency without any risk or harm to patients. It will be used in numerous and
diverse residency, nursing and allied health educational programs for basic gynecology training. The Miya
Model™ system will also be used by hospitals for credentialing and medical device companies for product
development and training.

Public health relevance
Miya%Model%Advanced%Gynecological%Training%Simulator: Narrative OB/GYN Residents do not receive adequate training in vaginal surgery techniques resulting in the inability to competently perform a vaginal hysterectomy, the hysterectomy technique recommended by The American College of Obstetricians and Gynecologists (ACOG) as it is associated with less morbidity, quicker recovery and lower costs than abdominal hysterectomy. Neither are OB/GYN Residents sufficiently trained in vaginal procedures to treat urinary incontinence, fecal incontinence or pelvic prolapse. The simulator being developed in this NIH SBIR research and development program will give OB/GYN residents the opportunity to be properly trained in vaginal surgery techniques and will have a profound impact on healthcare for women as well as help control medical costs.